Infection and Inflammation as Drivers of Aging (IIDA) Predoctoral Training Program

PROJECT SUMMARY
The most profound demographic change confronting our world is a dramatic increase in individuals over
65 years of age, projected to reach over 80 million people in the US and 1.5 billion worldwide by 2050. The
increasing number of older adults has major socioeconomic ramifications. First, the increase in longevity
dramatically increases numbers of older adults with multiple chronic diseases and with reduced quality of life.
Second, the challenge of managing the health care of older adults consumes a disproportionally large segment
of health care dollars. Therefore, biomedical innovations must target increasing resilience and healthspan in
older adults. The COVID-19 pandemic starkly illuminated the heightened risk of viral infection in the elderly.
Robust and expanded training in biomedical sciences pertinent to the biology of aging is critical to address the
needs of the growing number of older adults. Our T32 renewal application is a multidisciplinary program designed
to train pre-doctoral investigators (6 per year) to define mechanisms underlying the roles of Infection and
Inflammation as Drivers of Aging (IIDA). The IIDA training program is comprised of basic scientists, clinicians,
and public health mentors at the University of Arizona (UArizona), a top 20 public Research I University,
recognized for its training history in the field of basic biomedical research and for its commitment to mentoring,
diversity (designated Hispanic-Serving Institution) and cross-disciplinary training. To address the complex
challenges of aging, we propose a graduate-level training program with 3 major synergistic themes: (i)
inflammation and immunity in aging, (ii) persistent infection in aging, and (iii) inflammation and age-related
pathology. The 27 NIH-funded faculty supporting this training program have expertise in infection, inflammation,
immunology, and age-related pathologies. The training program is supported by a number of UArizona strengths
in aging, basic sciences, clinical practice, and public health. The goal of the IIDA is to harness these strengths
to train the next generation in the underserved area of infection and inflammation as drivers of the aging process.
Extensive institutional support, state-of-the-art core facilities, and clinical and public health mentorship will
enhance the training experience. IIDA trainees will be exposed to cutting-edge, innovative science through the
participation in colloquia, seminars, data blitzes, and journal clubs, as well as through their engagement with the
EAB, the training faculty, and distinguished scientists in the aging field. IIDA also provides unique opportunities
to students to develop professional skills in advocacy and networking. IIDA also has a robust underrepresented
population (URP) outreach plan and diversity-building component. IIDA program provides exceptional training
for the next generation of diverse scientists to advance our understanding of the biological basis of aging
processes and develop strategies to enhance resilience and healthspan.

Public health relevance
NARRATIVE This multidisciplinary training program is designed to train pre-doctoral students (6 per year) to investigate the underlying the roles of Infection and Inflammation as Drivers of Aging. Increased training in biomedical sciences pertinent to the biology of aging is critical to address the needs of the growing number of older adults, that will make over a quarter of the US population and ~1.5 billion people worldwide by 2050. Specific training in the roles of infection and inflammation as drivers of aging will help understand and treat sources of inflammation that propagate and aggravate many chronic diseases of old age, including arthritis, cancers, cardiovascular, metabolic and neurodegenerative diseases, like Alzheimer’s and Parkinsons.